OUTREACH CORE

ABSTRACT/SUMMARY: OUTREACH CORE
Our team has over 20 years' experience working in community engaged research in both the East and West
coast of the country with various population groups, including Blacks, Latinos of various country origins,
Asian/Pacific Islanders, American Indians, and low socioeconomic status Non-Hispanic Whites. We will bring
this expertise as a group to this core to support the work at the community level of the Florida-California
Cancer Research, Education and Engagement Health Equity (CaRE2) Center. We have been engaged in
research and practice in the elimination of cancer disparities and in the inclusion and dissemination of scientific
data among various audiences. We have actively engaged communities both in community-based and
participatory research and other outreach, engagement and inclusion activities in diverse populations. The goal
of the Outreach Core (OC) in the Center is to organize and support the various investigators engaged in
prostate and pancreatic cancer research by providing mechanisms for community input as well as for the
dissemination of scientific information to high risk communities, and engagement in Center activities. The OC
will function as a two-way bridge between our two main communities of focus, Blacks and Latinos, on each
coast, and will facilitate integration of ideas, collaboration, inclusion into the research and dissemination of
information to community stakeholders (community residents, partners, key opinion leaders and policy makers,
community advocates). We will also evaluate the impact of our activities at the community level. To accomplish
our goals, we propose four aims, focused on outreach programs for Blacks and Latinos. Our overall
dissemination goals are to develop and release information to increase public awareness about pancreatic and
prostate cancer in Blacks and Latino populations, reach influential audiences (policy makers, cancer related
practitioners), increase visibility for these issues and name recognition for the Center in all of our Universities
and internal audiences, as well as external audiences.